Administrative Core

ABSTRACT - ADMINISTRATIVE CORE
The goal of Advance Clinical and Translational Research (Advance-CTR) is to bridge the gaps between the
worlds of clinical and basic science by developing a multi-institutional, clinical translational research
infrastructure that beneficially impacts clinical practice and health care policy in Rhode Island. We will
leverage Rhode Island’s educational institutions, streamlined clinical environment, and IDeA sponsored
research mentoring programs and state of the art research infrastructure to enhance clinical translational
research by supporting the research, training, management, oversight, and coordination processes needed
to transform the clinical and translational research environment in our participating institutions. The
Administrative Core is responsible for the leadership and management structure for effectively managing,
coordinating and supervising the Advance-CTR. The leadership structure builds upon the Culture of
Collaboration demonstrated by the numerous examples of inter-institutional high impact awards that have
been received and that support this IDeA-CTR. The structure ensures representation by working across a
statewide consortium of universities, hospitals, government agencies, non- profits, industry partners, and
the Departments of Health to impact the health of Rhode Islanders. Within Brown University, Advance-CTR
collaborations extend across the Division of Biology and Medicine, the Alpert Medical School, the Program
in Biology, the School of Public Health, the School of Engineering, and other Institutes and Centers. At the
University of Rhode Island, we impact the Colleges of Pharmacy, Nursing, and Environment & Life Sciences.
Through strategic partnerships with the Rhode Island Quality Institute and access to the All Payor Claims
Database, we are able to evaluate the health care of all of Rhode Islanders through truly population based
epidemiological studies, population phenotyping and clinical surveys. This IDeA-CTR proposal has the
following Specific Aims: 1) Provide the organizational structure, leadership, governance, and advisory support
to develop, maintain, and enhance Advance-CTR Core activities in support of clinical and translational
research. 2) Enable the development, coordination, and implementation of strategic initiatives and manage the
business, financial, communication, and evaluation functions necessary to ensure efficient operations and to
foster growth and the long-term sustainability of Advance-CTR. 3) Serve as a source for developing written
policies and procedures necessary for effective organization governance and long-term sustainability of
Advance-CTR and retention of clinical research investigators.